A broad catalog of transcriptomic and proteomic markers for human cell senescence

The accumulation of senescent cells is a driving force of aging decline and age-related diseases. Even though cellular senescence has been defined in detail in cultured cells, current knowledge of senescence in vivo is very limited, due in part to the complexity of organisms of cells in tissues and organs. To gain a better understanding of senescence in vivo in the organism, we propose to create a comprehensive catalog of senescence models in a large subset of human primary cells, where we will profile the transcriptome, proteome, and secretome. This characterization will enable the identification of both shared and organ/lineage-specific senescence markers, to uncover markers to study cellular senescence in vivo. Finally, we plan to validate all these findings in well-known in vivo models of senescence, such as aging and chemotherapy-induced senescence. We anticipate that the completion of this project will pave the way for a more systematic study of cellular senescence and its connections to aging physiology and disease.